Enhancing the Impact of Evidence-Based Prevention for Youth: The Rapid Adaption to Prevent Drug Use (RAPD) Implementation Strategy

Drug use trends change rapidly among youth, leaving intervention experts struggling to respond to emerging
drugs promptly. We have a critical need to advance implementation strategies to optimize system
responsiveness to these emerging issues. COVID-19 has increased the urgency for implementation science to
facilitate rapid, equitable responses using existing treatment and prevention efforts. Tier 1 evidence-based
interventions (EBIs), such as the Michigan Model for HealthTM (MMH) lend themselves to addressing emerging
trends. Our overall objectives are to 1) Improve the responsiveness of school-based EBIs in addressing urgent
issues and 2) Find ways to support teachers in implementing updated EBIs, attending to unique considerations
of low-resource schools. We will use After Action Review (AAR), to guide the systematic design of RAPD,
Rapid Adaptation to Prevent Drug use, a novel bundle of implementation strategies. AAR is a reflective
process focused on improving public health systems’ rapid response capacity. Key phases of AAR include: 1)
Objective observation; 2) Analyze gaps/best practices, 3) Identify and test suitable implementation strategies to
improve responsiveness to the next event (e.g., COVID-related drug use escalation). Sustainable strategies
are central to achieving our objectives. Thus, we will also conduct a preliminary stakeholder-focused cost
analysis. The rationale for this research is that designing and testing RAPD will enhance schools’ capacity to
respond to urgent drug issues sustainably, and provide up-to-date, relevant resources for effective and
equitable prevention. The proposed research will address the following aims: Aim 1: Identify implementation
gaps and best practices in responding to urgent drug use events. We will use AAR to review the statewide
response to the vaping crisis using the MMH using rapid qualitative analysis and identify gaps to be addressed
with RAPD. Aim 2: Design and pilot test RAPD implementation and effectiveness. We will design a RAPD to
optimize responses to urgent drug use events and pilot test in schools serving low-income students to assess
equity. We will assess implementation outcomes using a convergent mixed methods design, and effectiveness
via a group RCT comparing RAPD and standard MMH implementation. Aim 3: Assess costs and benefits of
RAPD from multiple stakeholder perspectives. We will use an exploratory sequential mixed methods design to
understand and identify key costs and outcomes from key stakeholder perspectives. We will develop a costing
guide and conduct a preliminary cost analysis to inform an economic evaluation for a larger trial. The proposed
research is innovative because to date implementation strategies have not been designed to support systems
in responding to changing public health trends with attention to equity. In addition, this study focuses on
implementation strategies to reduce the health impact of emerging drugs and provide an infrastructure to make
future adaptations that can be applied in other contexts. The proposed research is significant because it will
advance applying implementation science to achieve access, cost and equity for drug use prevention.

Public health relevance
This is a novel study focused on designing and testing an implementation strategy bundle, Rapid Adaptation to Prevent Drug use (RAPD). RAPD will help optimize the capacity of schools respond to emerging drug use issues by reflecting on gaps and best practices from previous responses (e.g., vaping), including inequities in responsiveness. This research will enhance the public health impact of existing evidence-based interventions, enhance equity and enable similar adaptations of future emerging drug use issues.